Transcriptional silencing of HIV by LTR targeting RNAi

One of the primary impediments to curing HIV is the existence of viral reservoirs in distinct compartments and
cell types that are unaffected by current antiretroviral therapies (ART). In the central nervous system (CNS),
reservoirs are comprised primarily of myeloid cells, such as microglia and perivascular macrophages. Because
HIV enters the CNS rapidly after initial infection, these reservoirs are established prior to initiation of ART. While
ART can enter the CNS and block the infection of new myeloid cells, it does not stop viral replication from an
integrated provirus. Thus, most of our current antiretrovirals have no effect on viral replication from chronically
infected myeloid cells allowing long-lived, infected CNS microglia to drive ongoing neuroinflammation and
provide a source of HIV for viral recrudescence. To prevent this, it is critical to precisely target viral replication in
these cells. Existing strategies to eliminate this reservoir have shown some promise in pre-clinical studies but
have not yet proven successful. This proposal pursues a novel, alternative strategy: employing RNA interference
(RNAi) to durably silence HIV transcription in myeloid cells. This will stop viral replication from these cells and
functionally eliminate the CNS reservoir through the “block and lock” strategy. To do this, we will evaluate an
approach that uses small RNA to induce transcriptional gene silencing (TGS) of the integrated LTR. Our
preliminary studies demonstrate the efficacy of inducing TGS through RNAi and also show changes in viral
output in chronically infected myeloid populations treated with ART. The state of viral output in myeloid cells is
distinct from T-cell latency and is increased by exposure to benzodiazepines. We hypothesize that treatment
with RNAi will induce a stable heterochromatic state, blocking proviral transcription and eliminating
production of new virions in chronically infected microglia. Thus, we have proposed studies that will develop
our RNAi based strategy to eliminated virion production in infected myeloid populations, providing an effective
strategy by which to nullify the CNS myeloid reservoir. Successful completion of this screen will provide
necessary data for further applications exploring specific applications of this technology and examination of
transcriptional dynamics in microglia using the described systems. To carry out these studies, we propose the
following Aim I: To identify and optimize LTR targeting RNAi for transcriptional silencing of HIV in myeloid
cells and Aim II: To determine the efficacy of RNAi candidates in iPSC-derived human microglia and
durability after LRA and benzodiazepine treatment.

Public health relevance
Persistent HIV replication from populations of macrophages and microglia in protected anatomical compartments like the brain is a central impediment to successfully curing HIV. However, the current strategies being used to attack these persistently infected populations by targeting and removing the virus have proven ineffective and have potentially dangerous side-effects. This proposal will develop a novel strategy to eliminate the production of HIV from these protected populations using transcriptional silencing, efficiently blocking the infected cells from producing new viral particles without needed to specifically target or remove infected cells.